Controlling NETosis to Treat Diabetic Wounds.

Title: Controlling NETosis to Treat Diabetic Wounds.
Project Summary
This Phase 1 STTR proposal is focused on establishing proof-of-concept studies aimed at developing a novel
humanized monoclonal antibody for the treatment of diabetic wounds. NETosis is a unique form of cell death
characterized by neutrophils releasing net-like structures known as "neutrophil extracellular traps (NETs)" to
combat bacterial pathogens. Initially lauded for its role in innate immunity, emerging evidence suggests the
adverse effects of excessive NETosis in both infectious and non-infectious diseases. Diabetic individuals
manifest a notable elevation in NETs-releasing products in their bloodstream, and uncontrolled NETosis has
been linked to impaired wound healing in diabetes and increased infection susceptibility. Citrullination of histone
H3 (CitH3) plays a pivotal role in initiating NETs-induced immune cell death and tissue damage. Elevated CitH3
has been identified as a risk factor for wound healing impairment and amputation in patients with diabetic foot
ulcer. To translate our basic findings on CitH3 into practical applications for humans, we have recently developed
a humanized anti-CitH3 monoclonal antibody (hCitH3-mAb). We have completed developability studies and
established a protocol for scaled-up production and purification of hCitH3-mAb, demonstrating superior binding
capabilities to CitH3 surpassing commercially available antibodies. In vivo studies have shown that hCitH3-mAb
improves survival in septic shock mouse models and enhances wound healing in diabetic mice. Our proposal
aims to formulate a topical delivery system for hCitH3-mAb, enabling sustained release for the treatment of
diabetic ulcers. Following this, we will conduct proof-of-concept studies utilizing hCitH3-mAb to treat diabetic
wounds in animal models. The successful completion of these studies brings us one step closer to submitting an
IND application to the FDA, potentially revolutionizing the treatment of diabetic ulcers.

Public health relevance
Project Narrative Wound healing impairment in diabetes, particularly with diabetic foot ulcer (DFU), poses significant risks of morbidity and mortality. Humanized monoclonal antibody represents potential effective means to mitigate chronic inflammation and boost the healing process of diabetic wounds.